The immunomodulatory role of Ankyrin repeat containing effectors expressed by Coxiella burnetii

C. burnetii causes the zoonotic disease Q fever and resides within monocytes/macrophages manipulating innate immune response. C. burnetii requires de novo protein synthesis and a functional Type IVB Secretion System (T4BSS) to modulate host the eukaryotic transcription factor Nuclear Factor-­κB (NF-­κB) signaling an essential regulator of innate response. Multiple pathogens including C. burnetii deliver eukaryotic-­type Ank-­containing effectors to hijack NF-­κB signaling. C. burnetii Nine Mile isolate encodes 5 Ank-­containing effectors (AnkA, -­C, -­F, -­G, and -­K). Experiments found that 1) AnkK and AnkC significantly contributes to C. burnetii’s ability to inhibit NF-­κB dependent gene expression and 2) ectopic expression of AnkK or AnkC in HEK293/hTLR4-­MD2-­CD14 cells blocks accumulation of NF-­κB in the nucleus. The central focus of this proposal is to determine mechanistically how the C. burnetii effectors, AnkK and AnkC, modulate NF-­κB to promote intracellular survival and replication. The central hypothesis by accomplishing the following specific aims: 1. Determine the contribution of AnkK and -­C to C. burnetii’s virulence. The working hypothesis is that C. burnetii AnkK and AnkC promotes pathogen virulence by modulating NF-­κB activation. To test this, we will generate complementation strains of C. burnetii NM II (NM II) ankK::Tn and ankC::Tn mutants and investigate in vitro growth rescue and p65 nuclear translocation for phenotype rescue in tissue culture cells. To investigate in vivo growth rescue, we will employ the SCID mice/NM II infection model. Employing CYA-­translocation assays, we will then test Type 4 secretion system requirement. Furthermore, we will generate ΔdotA, ΔAnkK, and ΔAnkC gene knockouts and their complementation strains in virulent C. burnetii NM I (NM I) to infect C57Bl/6N mice and determine the relative contribution of AnkK and AnkC to bacterial virulence in vivo. 2. Determine the mechanism of AnkK/AnkC-­dependent NF-­κB inhibition during C. burnetii infection. The working hypothesis is C. burnetii AnkK or AnkC interacts with host targets in the canonical NF-­κB pathway or potentially sequesters p65 to block its nuclear translocation. We will deplete p65 in host cells to investigate growth rescue of NM II ankK::Tn and ankC::Tn mutants. We will examine expression, phosphorylation and degradation status of individual components of the canonical NF-­κB pathway in stable THP-­1 cell lines expressing eGFP-­tagged AnkK and AnkC. To identify host-­binding partner(s), pull down assays (GFP-­trap) will be performed with THP-­1 stable cells expressing eGFP-­AnkK and ?AnkC. To determine C. burnetii AnkK or AnkC driven modulation of host p65-­dependent gene expression in infected cells, we will perform scRNA-­seq and p65/ChIP-­ seq experiments.

Public health relevance
Project narrative Coxiella burnetii, the intracellular bacterial pathogen the causes Q fever, express a variety of secreted effector proteins that modulate host function to enable replication in macrophage/monocytic cells. This project will determine the role of two effector, AnkC and AnkK, in the modulation of the transcriptional regulator NFkB and define the molecular mechanisms that lead to stealthy pathogenic virulence.